A Mixed-Methods Study of the Ethical Issues Surrounding Mobile Sensing in Digital Mental Health Interventions

Abstract
There is a crucial need for scalable, accessible mental health treatments that are delivered outside of clinics
and can be integrated into daily life. Just-in-Time Adaptive Interventions (JITAIs) delivered via smart-
phones and wearables represent a promising method to increase access to cost-effective and acceptable
mental health care, and tailor in-the-moment interventions to best match the speciﬁc context of the individ-
ual and their personal stressors, and determine when the individual is most likely to beneﬁt from the inter-
vention. However, these more scalable, personalized, context-sensitive interventions raise ethical questions
tied to patient consent and acceptability, intrusiveness of monitoring, privacy and data security tied to both
the collection of sensitive data and the associated computational methods applied. The main objective of
this supplement is to answer these crucial ethical questions related to leveraging mobile sensing, wear-
ables, and computational methods for socially anxious individuals in the context of digital mental health
interventions. To our knowledge, this work is the ﬁrst to tackle the speciﬁc ethical concerns for conducting
research with mobile sensing devices with individuals high in social anxiety, which is especially important
given this population has strong fears of evaluation and self-consciousness. To address this need, in Study
1, N=20 individuals high in trait social anxiety will be invited to engage in 1-hour, one-on-one, in-person
interviews. We will follow a semi-structured interview guide to enquire about views toward wearable sen-
sors (particularly watches) and passive monitoring on mobile phones. In Study 2, we will do a secondary
data analysis, leveraging data collected from a group of socially anxious (N=46) participants as part of
our R01 parent grant. Speciﬁcally, we will use existing data to empirically investigate the risk of person
re-identiﬁcation (i.e., predicting a participant's identity using features extracted from sensed data streams).
More broadly, we will identify the key factors (e.g., individual, modalities/sensors, and contextual differ-
ences) that contribute to privacy risks in biobehavioral data. After identifying the key factors contributing
to privacy risks, we will develop and test privacy-preserving techniques that are tailored to those factors,
to minimize the privacy risks while still obtaining valuable insights from the data. For JITAI's to meet their
promise, we need to understand socially anxious individuals' preferences about different types of mobile
sensing, various combinations of data streams, risks of sharing the resulting data with different people, and
trade-offs between privacy on the one hand and knowledge production and clinical efﬁcacy on the other
hand. Together, this work will inform guidelines for researchers and practitioners so they can beneﬁt from
mobile sensing and JITAIs in a way that is ethical and patient-centered, while not compromising model
performance.

Public health relevance
Project Narrative Social anxiety disorder (SAD) is one of the most prevalent mental disorders, affecting 12.1% of U.S. indi- viduals at some point in their lifetime, and is characterized by fear and avoidance of socially evaluative situations, often leading to devastating consequences for the affected individual and placing considerable economic burden on society at large. The proposed study is the ﬁrst (to our knowledge) to tackle speciﬁc ethical concerns for conducting research with mobile sensing devices in individuals high in social anxiety (a group likely to have heightened concerns about being monitored), considering aspects of both users' comfort and perceptions of leveraging digital health interventions with embedded sensing, as well as the preferred methods and content of informed consent to communicate about potential risks. The outcomes of this work will contribute to best research and clinical practices in the ﬁeld of digital mental health for socially anxious individuals.